Determining Host-microbiome guided oro-nasal fistula healing

SUMMARY
Cleft palate formation is one of the most common craniofacial anomalies in children and occurs in 1:1000 live
births. Patients undergo multiple surgeries during their lifetime and, for many, the first surgery is the repair of
their cleft palate. However, 60% of cleft palate patients suffer poor wound healing following surgery which
leads to the development of an oro-nasal fistula (ONF) characterized by a continued communication between
the oral and nasal cavities. The primary approach to repair an ONF is by using human donor tissue, which acts
only as a physical barrier and carries the risks of disease associated with human donor tissue, such as prions
or HIV infection. Therefore, there is an urgent need to develop new therapeutic strategies to improve wound
healing after cleft palate surgical repair, and to reduce the cases of ONF. Wound healing has been studied
extensively on the skin and particularly following intestinal injury. Intestinal wound healing efficiency is highly
sensitive to environmental factors, especially the microbiome, where specific microbial community structures or
supplementation with probiotic bacteria enhances the wound healing process. However, little is known about
how the oral microbiome affects ONF wound healing. We directly address this gap in the knowledge and show
preliminary data that creating an ONF in a murine model results in marked changes in the microbiome
composition, with the complete disappearance of certain microbes, and blooms of other bacterial taxa. Based
on this premise, in Aim 1, we will create ONF wounds in germ-free mice, or in conventionally raised mice
treated with antibiotics, and assess healing rates and changes in the oral microbiome composition. We expect
to show the influence of disrupting the oral microbiome on healing processes and ONF formation. In Aim 2, we
will use a hydrogel to re-introduce commensal oral microbes lost following surgery to the site of the oral wound
and assess healing rates. We expect to show that repletion of oral commensal bacteria to the wound site can
promote wound healing processes. In addition, by assessing transcript enrichment by RNA-seq within ONFs in
germ-free, antibiotic treated mice, and after the repletion of oral commensal bacteria, we expect to identify
gene networks that function in healing within ONFs that are sensitive to the commensal oral microbiome. Thus,
our overall hypothesis is that the oral commensal microbiome exerts positive modulatory influences on oral
wound healing and may limit ONF formation. Discovering specific bacterial taxa within the oral cavity or wound
tissue that positively influence healing will be essential information for the characterization of an eubiotic oral
microbiome for wound healing. Our experiments will also generate critical information for clinicians about the
prudent use of antibiotics after cleft palate surgery and the effects of depleting the oral microbiome during
healing. We will also substantiate the approach of the repletion of the oral commensal bacteria using hydrogel
technology as the vehicle to enhance oral wound healing. Together, these studies will yield critical data to
inform new therapeutic modalities to lower the prevalence of ONFs following cleft palate surgery.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health as cleft palate is the most common craniofacial congenital anomaly and cleft palate repair is associated with wound healing complications in up to 60% of patients, resulting in an oro-nasal fistula (ONF). ONF occurrence is associated with poor feeding and speech and typically requires multiple additional surgeries to repair. This proposal is relevant to the NIH’s mission to understand host-microbiome interactions and to develop innovative therapies and in this proposal we propose to characterize the importance of the microbiome-host relationship during oral cavity wound healing and test the pro-regenerative capabilities of probiotics.